The Role of CCL11 in Inflammatory and Sporadic Colorectal Cancer.

With more than 3 million Americans affected, inflammatory bowel disease (IBD) causes significant morbidity and
can progress to colorectal cancer (CRC). There are two main forms of IBD: ulcerative colitis (UC) and Crohn’s
disease, and the associated abnormal immune response continues to be investigated with the hope that new
therapeutics can be developed. CRC is the 3rd most common cancer and 2nd leading cause of death in men and
women combined and colitis-associated cancer (CAC) is a subset of CRC. Sporadic CRC is also a major clinical
problem in Veterans. We have previously shown in a prospectively collected cohort of adult UC patients, CCL11,
classically described as an eosinophil chemoattractant, was the only analyte increased in both serum and tissue
compared to non-IBD controls. Ccl11-deficient mice have been shown to be protected from colitis in an acute
dextran sulfate sodium (DSS)-induced colitis model. However, acute colitis studies in mice lacking eosinophils
(including ΔdblGATA mice) have been mixed, suggesting it is not simply just decreased tissue eosinophil
infiltration leading to improvement in colitis. We have reported that Ccl11-deficient mice exhibit decreased tumor
number and burden in the azoxymethane (AOM)-DSS CAC model. CCL11 has also been shown to be increased
in sporadic CRC. We have now found that 1) mice with epithelial cell-specific loss of CCL11 (Ccl11∆GIepi) exhibit
decreased tumor number and burden in the AOM-DSS model; 2) tumors from CDX2P-CreERT2Apcfl/fl mice (CRC
model due to altered adenomatous polyposis coli (Apc) expression) exhibit increased CCL11 expression; 3)
epithelial cell-specific loss of CCL11 in CDX2P-CreERT2Apcfl/flCcl11fl/fl mice leads to decreased tumor number
and burden; 4) tumorigenesis is not altered in ΔdblGATA mice in the AOM-DSS model or in CDX2P-
CreERT2Apcfl/flΔdblGATA mice, 5) human colonoids express receptors for CCL11; 6) recombinant CCL11
(rCCL11) leads to decreased colonic epithelial wound restitution; and 7) tumors from Ccl11∆GIepi mice exhibit
decreased levels of pERK1/2 indicative of MAPK activation, which is frequently implicated in CRC development.
We propose to investigate the role of epithelial-derived CCL11 in oncogenic epithelial dysfunction in models of
CAC and sporadic CRC. We will use Veteran patient-derived colon tissues and organoids to validate our animal
studies and develop rationales for future human studies. Our Hypothesis is: CCL11 dysregulates epithelial
function and supports carcinogenesis via MAPK/ERK signaling in inflammatory and sporadic colon
cancer. The Specific Aims are: 1. To test the hypothesis that CCL11 activates MAPK/ERK signaling
predisposing to CAC via epithelial dysfunction. Ccl11∆GIepi and ΔdblGATA mice exposed to AOM-DSS will
be used to test the hypothesis that CCL11 leads to epithelial dysfunction via MAPK/ERK signaling in murine
models and organoids. 2. To test the hypothesis that CCL11 signaling promotes sporadic CRC driven by
somatic mutations via dysregulating epithelial function and promoting oncogenic signaling. CDX2P-
CreERT2Apcfl/fl and CDX2P-CreERT2Apcfl/flCcl11fl/fl mice will be used to test the hypothesis that epithelial CCL11
promotes tumor development by assessing tumor number and size and epithelial function. Epithelial function
and oncogenic signaling will be assessed in murine organoids and HCT116 cells exposed to cytokine cocktails,
rCCL11, an anti-CCL11 antibody, and with CCL11 receptor knockdown 3. To test the hypothesis that CCL11
signaling dysregulates epithelial function and promotes oncogenic signaling in tissues and patient-
derived colon organoids (PDCOs) from Veterans. CCL11 is increased in IBD patients, CAC, and CRC. We
will compare genomic alterations and transcriptional profiles in normal, IBD, CAC, and CRC samples to CCL11
expression and epithelial function and oncogenic signaling pathways. Epithelial function and oncogenic signaling
will be assessed in PDCOs exposed to cytokine cocktails, rCCL11, an anti-CCL11 antibody, and with CCL11
receptor knockdown. These studies will lead to new insights that could identify molecular-based approaches to
improve patient risk stratification and identify new treatment strategies based on modulation of CCL11 signaling.

Public health relevance
Colorectal cancer (CRC) is the 3rd most common cancer and 2nd leading cause of death in men and women combined, and colitis-associated cancer (CAC) is a subset. Multiple studies have suggested a link between CRC and bacterial factors or inflammation, and the link between inflammatory bowel disease (IBD) and colonic pre-cancerous lesions and cancer itself is firmly established. The cumulative probability of developing cancer in ulcerative colitis depends greatly on disease duration, and is 2% by 10 years, 8% by 20 years, and 18% by 30 years. The prevalence of IBD is increasing among VA healthcare system users. Veterans with IBD develop CRC at a younger age and are more likely to develop right-sided colon cancer. CRC, including CAC, represents a significant health problem for our Veterans. Therefore, there is an ongoing need to discover new approaches for improving patient risk stratification and/or novel treatment strategies; we aim to establish CCL11 as an important target.